Transspinal versus Epidural Stimulation for Exoskeletal Assisted Walking after Spinal Cord Injury

Restoring locomotion following spinal cord injury (SCI) has been the focus of years of research aimed at
ameliorating several of health-related comorbidities. Spinal cord epidural stimulation (SCES) exhibits the
rehabilitation potential of restoring locomotion in individuals with SCI when combined with intensive locomotion
training. Despite this potential, such protocols are likely impractical when applied across large clinical SCI
populations due to high monetary costs. Similar to SCES, transspinal stimulation (TS) has also exhibited
neuromodulatory benefits by externally stimulating lumbro-sacral neural circuity to generate step-like activities
in persons with complete SCI; however, these techniques also require intense gait training. Recently robotic
exoskeletons have been used as a promising tool to circumvent limitations associated with labor-intensive
locomotor training, and have been safely used as an effective approach in improving levels of physical activity
in persons with complete SCI.
Recent work has demonstrated the benefits of combining EAW and neuromodulatory techniques. Following
12-weeks of EAW+SCES training, improvements in locomotion led researchers to decrease the amount of
EAW swing assistance to 35% in a person with a C7 complete SCI. This was accompanied by 573 unassisted
steps, which represents 50% of the total number of steps taken during that session. Electromyographic (EMG)
activity also increased during both stance and swing phases, reflecting the individual’s ability to rhythmically
fire paralyzed muscles during EAW+SCES. Additionally, cardio-metabolic loads were increased during
exoskeletal stepping when combined with SCES as compared to stepping without SCES. The participant also
showed a modest decrease in his total and regional absolute fat mass. These preliminary findings suggest that
neuromodulation using SCES with exoskeletal ambulation may provide a feasible rehabilitation approach for
persons with SCI. The goal of the current study is to examine and compare the effects of EAW combined
with SCES or TS in persons with motor complete SCI. The data generated from this application will also enable
larger clinal trials to explore ways to optimize exoskeletal assisted gait training through the use of different
neuromodulation modalities with SCI.
Following a repeated-measure design, 10 participants with chronic, motor complete (AIS A and B) SCI
(age:18-60 years) will be randomly assigned to participate in either 6-months of EAW+SCES (n=5) or
EAW+TS (n=5) training. The entire duration of the trial will be approximately 1 year for each participant.
Initially, participants will undergo 3-months of EAW training (3 sessions/week), which will be followed by
randomization into either a EAW+SCES group or EAW+TS group for an additional 6-months of training (both
groups: 3 sessions/week) and a 3-month follow-up period for both groups. Measurements at baseline (BL:
prior to EAW) and 4 post-intervention timepoints will occur every 3-months (P1: following 3-months of EAW;
P2: following 3-months of EAW+TS or EAW+SCES; P3: after completing 6-months of EAW+TS or
EAW+SCES; P4: 3-months after termination of EAW+TS or EAW+SCES). This pilot work will have 3 specific
aims: Aim 1. We will determine and compare improvements to locomotor control following 6 months of
EAW+TS and EAW+SCES as measured by 10-meter walking speed, the number of unassisted EAW steps,
and EMG activity. Aim 2. We will determine and compare improvements to cardio-metabolic risk factors
following 6 months of EAW+TS and EAW+SCES as measured by total and regional body composition, oxygen
uptake, and fasting lipid profile. Aim 3. We will determine and compare improvements in bladder health
following 6 months of EAW+TS and EAW+SCES as measured by bladder filling and emptying.

Public health relevance
Spinal cord injury (SCI) leads to several health-related consequences often linked to reduced levels of physical activity. Direct stimulation of the spinal cord, either through implanted devices or surface stimulation, has been combined with intense physical therapy assisted treadmill walking to facilitate independent standing and stepping. These current methods require 3-4 highly skilled therapists and may not be feasible in all rehabilitation settings, especially when considering the growing number of SCI patients each year. Therefore, the use of robotic exoskeleton suits combined with direct stimulation of the spinal cord (requiring 1-2 therapists) may offer an alternative rehabilitation approach to overcome their limited abilities to stand and walk. Such improvements may also help to reverse or eliminate other health-related consequences associated with SCI. The pilot work will provide the preliminary evidence required to design future clinical trials for Veterans and civilians with SCI to restore overground mobility.